95GHZ SPECTROMETER EXPERIMENTAL SCRIPTING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. With the extensive reworking of the 95 GHz pulse spectrometer software and hardware, it was realized that a suite of utility scripts for assessing various aspects of spectrometer performance would be extremely useful. Due to the streamlined, transparent way in which the code base has been updated, writing such utility scripts is now much easier. We have been working with Drew Dolgert of the Cornell Center for Advanced Computing to implement these utility scripts in portable, easily understandable python. Dr. Dolgert's expertise has been crucial for ensuring that the python implementation of the utility scripts follows universally recognized python conventions and best practices across multiple available python versions.